Sex Differences in E-Cigarette Flavor Sensory Perception As It Relates to Appeal and Reinforcing Efficacy Among Adult Smokers

Project Summary
Female cigarette smokers have been shown to be more sensitive than males to non-nicotine sensory cues,
which may explain lower rates of smoking cessation and lowered response to nicotine replacement therapies
among females. Additionally, evidence suggests females have higher use of non-tobacco e-cigarette flavors
and value flavor availability. This proposal seeks to elucidate how sex may influence the sensory perception of
the popular e-cigarette flavor components, sweetness and cooling, and how this impacts appeal and
reinforcing efficacy. We plan to examine sensory perception, appeal, reinforcing efficacy of three e-cigarette
flavors (sweet flavor, cooling flavor, and unflavored) in an e-cigarette with moderate nicotine concentration
when presented alone (Aim 1) and concurrently (Aim 2). We hypothesize that compared to an unflavored e-
cigarette liquid, sweet and cooling flavor components will be generally rated as more appealing and reinforcing
among both males and females, but females will have more pronounced differences in appeal and reinforcing
efficacy of sweet and cooling flavors compared to the unflavored e-liquid (Aim 1). Additionally, we hypothesize
that females compared to males will work harder and demonstrate greater abuse liability for flavored e-liquids
in nicotine containing e-cigarettes when concurrently available with unflavored e-liquids in nicotine containing
e-cigarettes (Aim 2). The outcomes of this project will provide new information about how the difference in
response by sex to the non-nicotine sensory cues of flavor inform e-cigarette use and behavior. Regulatory
efforts to restrict popular flavor components, like sweet and/or cooling flavors in e-cigarettes may have
potentially a greater impact on female cigarette smokers than males on use of e-cigarettes as a potential harm
reduction tool.
Through expert mentoring, directed readings, formal coursework and seminars, direct experimental training,
attendance at scientific meetings, manuscript and grant preparation, expertise to conduct the proposed
research will be gained in the following areas: (1) chemosensory psychophysics as it relates to tobacco
regulatory science, (2) sex-related research as it relates to tobacco regulatory science, and (3) advanced
statistical training aimed at developing data analysis techniques to investigate sex differences & flavored
tobacco product use. Taken together, this research project and training plan will provide an important
framework for career development in tobacco regulatory science.

Public health relevance
Project Narrative This study will evaluate how sex (female, male) is associated with sensory perception, appeal, and reinforcing efficacy of e-cigarette flavors in nicotine containing e-cigarettes among adult smokers. Given the low rates of cessation among female compared male smokers and its potential relationship with non-nicotine sensory cues, this proposal will elucidate the role that perception of popular flavor components (sweet, cooling) plays in e- cigarette use, behavior, and abuse liability and how this role differs by sex. The outcomes of this project will provide the FDA with new information in key areas (Behavior, Addiction) to inform potential sex differences in response to e-cigarette flavor regulations with the aim of protecting overall public health.